SWOG Network Group Operations Center of the NCTN

The Administrative Core provides essential infrastructure linking our member core and clinical trials development teams. It provides expert guidance and oversight to SWOG, develops and maintains our Operations Center organizational structure and policies, and supports an up-to-date set of Standard Operating Procedures that cover all aspects of the Network Group’s activities.

Public health relevance
N/A